How are necrotic neurons recognized by their phagocytes

In an animal’s life, a large number of cells undergo apoptosis – cell suicide, to support development
and maintain body homeostasis. In addition, during stroke, cancer, and other traumatic situations, a large
number of cells undergo necrosis after injury. These cells are rapidly internalized by other cells via
phagocytosis (engulfment) and degraded inside engulfing cells. The swift removal of dying cells prevents
tissue injury, inflammatory responses, and auto-immune responses, clears the wounded area, and promotes
tissue repair. Necrosis is also closely associated with neuron degeneration. The phagocytosis of necrotic
neurons and axon debris facilitates the repair and recovery of neuron functions. Phagocytic activity by the
microglia also contributes to the loss of synapses in Alzheimer’s disease. My long-term goal is to understand
how dying cells are specifically recognized, internalized, and degraded by engulfing cells, using the nematode
Caenorhabditis elegans as a model organism. As many physiological mechanisms are highly conserved
throughout evolution, what we learn from C. elegans can be translated to humans. This proposal investigates
the mechanisms that promote the exposure of phosphatidylserine (PS), an “eat me” signal, on the surfaces of
necrotic and apoptotic cells to attract engulfing cells. In C. elegans, the necrosis of six mechanosensory
neurons (also called touch neurons) is induced by mutations in a particular group of plasma membrane ion
channel proteins, including the dominant mutations in MEC-4, a subunit of the mechanosensory Na+ channel.
We found that two proteins, the ABC transporter CED-7, and ANOH-1, the worm homolog of the mammalian
phospholipid scramblase TMEM16F, act in parallel to promote PS exposure on the surfaces of necrotic cells.
Recently, we have identified that the exposure of PS on necrotic cells is mediated by cytoplasmic Ca2+.
Furthermore, we discovered two alternative mechanisms that increase Ca2+ level in the cytoplasm, one
dependent on the release of Ca2+ from the endoplasmic reticulum (ER), the other independent of the ER. In
addition, we have identified multiple genes that act to regulate PS exposure. To further investigate the
molecular mechanism(s) of PS exposure, I propose to determine the novel functions of a transthyretin-like
protein and a proposed PS flippase in promoting the exposure of PS on the surfaces of necrotic cells in
response to the Ca2+ signaling (Aims 1 and 2), and to identify new PS-exposure genes from mutants defective
in the exposure of PS on dying cells that we isolated in a forward genetic screen (Aim 3). In this diversity
supplement application, Jonathan Pickett, a graduate student, will expand Aim 3 by identifying the roles of a
new family of proteins (Bridge-like Lipid Transfer Proteins) and bulk lipid transfer events in the recognition of
dying cells and the initiation of engulfment. Together, the outcomes will allow us to establish pathways that
promote PS exposure in response to upstream signals. They will also reveal novel molecular mechanisms
regulating each step of the process, some of which are anticipated to be unique to necrotic or apoptotic cells.

Public health relevance
During stroke, cancer, and other traumatic situations, many cells undergo necrosis and apoptosis after injury; the swift removal of these cells prevents tissue injury, inflammatory responses, and auto-immune responses, clears the wounded area, and promotes tissue repair. Necrosis is closely associated with neurodegeneration. Understanding the mechanisms controlling the recognition and engulfment of necrotic neurons will have important therapeutic implications in fighting chronic inflammatory and auto-immune diseases, and in treating neurodegenerative diseases and stroke.